Biospecimen and Pathology Core

ABSTRACT: BIOSPECIMEN AND PATHOLOGY CORE
The purpose of the Biospecimen and Pathology Core is to provide biospecimens and pathology services to
support the two planned Li-CAD P20 Projects and those research studies proposed in the context of the
Developmental Research Program and to prepare for a P50 SPORE expansion of services. The Biospecimen
Core provides expertise in the interpretation of tissue-based assays especially in the context of biomarker
studies, ensures quality standards and the ethical use of biospecimens and provides Core services in
histology, digital histology, immunohistochemistry and microdissection for Li-CAD investigators.
SA1. Provide biospecimens needed for Projects 1 and 2 from AI/AN patients with liver disease,
cirrhosis and HCC, as well as from appropriate non-AI/AN comparison/control patients
Our Li-CAD project will obtain plasma, serum, liver tissue and HCC tissue specimens from the following
biorepositories that will support the Li-CAD P20 studies: 1) a truly remarkable and unique biospecimen bank of
samples from Alaska Native (AN) patients with chronic liver disease (“AN biorepository”) from the Alaska Native
Tribal Health Consortium (ANTHC); 2) a biospecimen bank of samples from American Indian (AI) patients with
chronic liver disease from the Cherokee Nation Health Service (CNHS) (“AI biorepository”) ; and 3) two large
non-AI/AN, multiracial/multiethnic biorepositories, that will provide comparison specimens from non-AI/AN
patients.
The AN biorepository includes >40,000 prospectively and longitudinally collected biospecimens from >3500
patients at the Liver Disease and Hepatitis Program of the ANTHC (Anchorage, AK). This is directed by Dr. Brian
McMahon, the PI of the Li-CAD Biospecimen Core and co-PI of the P20 Li-CAD, which will serve to streamline
access to these biospecimens for Li-CAD investigators. Biospecimens from these biorepositories will support
Projects 1 and 2, as well as future developmental research projects and expanded P50 projects
SA2. Expand the biospecimen repository of American Indian patients with liver disease, cirrhosis and
HCC based at Cherokee Nation Health Service (CNHS, Tahlequah, OK) and pattern it after our existing,
large biorepository of Alaska Native patients at ANTHC.
We will augment our biospecimens and patient recruitment from American Indian patients by a new
collaboration with Cherokee Nation Health Service (CNHS). We will use our expertise from Alaska Native
biorepositories to establish analogous liver disease biorepositories for American Indian patients at CNHS. This
will be an invaluable resource, especially as we expand to a P50 SPORE.
SA3. Provide core pathology resources in histology, digital histology, immunohistochemistry and
microdissection for Li-CAD investigators

Public health relevance
While deaths related to lung, breast, prostate and colorectal cancer have declined dramatically by 40-53% between 1990 and 2016, hepatocellular carcinoma (HCC) is the only major malignancy whose mortality is rising in both men and women and has had the highest average annual percentage change. American Indian/Alaska Native (AI/AN) people face a disproportionally high burden of HCC with 2.4 times higher HCC incidence and 2.5 times higher HCC-related mortality than white persons. Our aim is to apply novel, innovative, translational approaches to surveillance and early detection of HCC that are informed by unique aspects of HCC pathophysiology and epidemiology in AI/AN people in order to eliminate disparities, improve early detection and ultimately reduce HCC-related mortality.